[R21] Integrated computer-aided, point-of-care ultrasound for tuberculosis screening

PROJECT ABSTRACT
Mycobacterium tuberculosis (TB, Mtb) is one of the leading causes of infectious disease mortality
worldwide, with a persistent gap in global case detection. In 2020, only 5.8 million of the estimated
9.9 million individuals who became ill with TB were diagnosed and reported. Active case finding
efforts to find these undetected cases by screening individuals in the community for TB is not
feasible in most resource-limited settings due to the large number needed to screen with sputum
microbiologic tests to detect one case. A rapid, highly sensitive point-of-care test that can be
performed in the field to screen for high-risk individuals can improve access to active case finding
by substantially reducing the number needed to test. Despite progress in the field, there remains
a lack of such tests that achieve both the point-of-care characteristics accessible for large-scale
screening and the target accuracy profiles for a triage or rapid diagnostic test. Point-of-care
ultrasound (POCUS) devices are low-cost, portable, avoid radiation exposure, and do not require
trained radiologic staff, making them amenable to wide scale with minimal resource needs. Lung
ultrasound has been found to diagnose adult pneumonia at a comparable to improved
performance level than chest-X-ray and holds promise as a TB triage test. Further application of
artificial intelligence-based computer aided diagnosis algorithms can further improve
reproducibility by automating and standardizing image interpretation, and potentially improve
performance as evolving AI platforms train on growing datasets. To explore the utility of POCUS
CAD for TB screening, we will conduct a systematic evaluation of POCUS for TB screening among
TB household contacts across a spectrum of early to advanced infection phenotypes. We will
additionally pilot an integrated computer-aided detection algorithm for POCUS-based detection
of pulmonary TB with the integration of clinical, exposure, and prevalence data to explore whether
these variables can increase specificity for TB. We will then evaluate performance profiles using
both deconstructed feature-based analysis and deep-learning algorithms to inform the potential
utility of POCUS as a TB triage test to enable widespread active case finding for the millions of
undiagnosed TB cases.

Public health relevance
PROJECT NARRATIVE Community-based screening for tuberculosis (TB) outside of hospitals and clinics is urgently needed to find the increasing missing millions of individuals with TB, but requires an affordable, rapid, and simple test. We will explore the utility of handheld point-of-care ultrasound (POCUS) using an integrated computer decision support algorithm to meet this need of an affordable large-scale screening test. This study will provide data, methods, and proof-of-concept to validate the performance and impact of POCUS for comprehensive and early TB case finding, to enable early treatment and reduction in TB transmission, disability, and death.